Multiplex discovery of synthetic host-protein combinations that inhibit HIV

PROJECT SUMMARY
Decades of HIV research have yielded a panel of potent HIV drugs, but we need the help of new approaches
to eliminate the global HIV epidemic. Modern biotechnologies have opened new avenues toward developing
engineered proteins that target the remaining vulnerabilities in the virus life-cycle. Novel protein combinations
linking host-derived HIV binding peptides with effector domains that can mark the HIV protein for degradation
may potently interfere with infection without causing major cellular toxicity. Unfortunately, there are hundreds to
thousands of combinations that need to be tested, which is nearly impossible using traditional, one-by-one
approaches.
We propose to apply cutting edge synthetic biology tools for protein and cell engineering, harnessing multiplex,
library-based assays to identify the most promising designs. In the first aim, we will perform large-scale
pairwise fusions of known HIV binding peptides with different cellular ubiquitin ligase effector domains, to
identify the combinations that have the best therapeutic potentials. The second aim uses an unbiased,
genome-wide transposon insertional mutagenesis approach to uncover novel binders capable of inhibiting HIV
replication when fused to a ubiquitin ligase domain. Both approaches will harness novel combinations of
protein sequences already found and expressed in humans, avoiding immune responses to non-self peptide
antigens. This work will yield new lead therapeutics, advance rational protein design, and provide biological
insight into how the stoichiometries of HIV protein targets and the multimerization of the engineered
proteasomal degradation machinery provides the most accurate and specific antiviral responses.

Public health relevance
PROJECT NARRATIVE Destruction of HIV proteins by retargeting proteasomal degradation machinery is a promising approach that can be combined with existing drugs to further curtail the worldwide HIV epidemic. These synthetic proteasomal targeting proteins can be engineered in thousands of different ways, and identifying the best designs is impossible with traditional one-by-one approaches. We will combine cutting edge protein and cell engineering techniques with pooled library experiments to identify novel combinations of human protein sequences that can potently inhibit HIV infection.